APICAL IF MEDIATE POST-ISCHEMIA RECOVERY IN EPITHELIA

DESCRIPTION (provided by applicant): The ishemia/reperfusion (I/R) injury results in loss of micro tubules (MTs) and F-actin in kidney proximal tubule cells. Using a model of mild ischemia (30-minute unilateral clamp of renal vessels) we have shown that those cytoskeletal elements are mostly repolymerized by day 3 after I/R, but polarization of the plasma membrane becomes normal only by day 5-7 , which parallels the normalization of kidney functional parameters. The observation of abnormal MT polarity during the late phase of the recovery after I/R, lead us to hypothesize that Microtubule-Organizing Centers (MTOCs) are redistributed at that time because an MTOC component, GCP6, which mediates attachment of MTOCs to intermediate filaments, is phosphorylated in a regulatory cassette located between aa 1395 and 1399. Therefore, I propose the following specific aims to test this hypothesis: 1. Determine the role of GCP6 in the attachment of MTOCs to keratin intermediate filaments under the apical domain of simple epithelial cells. 1.1 Determine the binding domains in GCP6 for keratins 8/19 using deletion mutants. 1.2 Define the binding domains in keratin 8 for GCP6 using the same method. 1.3 Over-express the mutants mentioned above to identify dominant-negative effects on the localization of MTOCs. 2. Characterize the phosphorylation of GCP6 by kinases known to block the attachment of MTOCs to keratins. 2.1 Identify the p34cdc2 and plkl phosphorylation sites. 2.2 Obtain an SB>D mutant of GCP6 in that site and verify its inability to bind keratin 8. 2.3 Overexpress such a mutant and analyze its localization and ability to organize the normal architecture of MTs. 3. Identify phosphorylation sites of GCP6 modified in vivo after I/R that account detachment of MTOCs during days 3-5 after I/R in proximal tubule cells and determine the consequences of a disarray of MTOCs on epithelial polarity. 3.1 Determine the kinetics of phosphorylation of GCP6-S1396 in post- ischemic kidney using a specific anti-phosphopeptide antibody, localize phospho-81396 GCP6, and determine the effect of specific blockers of GSK3 on MTOC distribution after I/R in vivo. 3.2 Obtain an S->D mutant of the phospho-site studied en 3.1 (possibly the GSK-3 site nearby SI 397), and verify lack of binding to keratins and the effect on MTOC localization in vivo. 3.3 Assess depolarization of apical plasma membrane proteins after blocking the attachment of MTOCs to apical IPs. The long term goal of the project is to characterize a signaling pathway responsible for the depolarization of MTOCs and plasma membrane proteins in the late stages of the recovery after I/R and to design an intervention to revert it and improve recovery times after I/R.